Coordination of Innate and Adaptive Immunity in Intestinal Barrier Defense

PROJECT SUMMARY
Coordination of Innate and Adaptive Immunity in Intestinal Barrier Defense. Intestinal barrier defense
requires the actions of both innate and adaptive immune cells on the mucosal epithelium. Tissue-resident and
mobile innate and adaptive immune cells each contribute to barrier defense in the intestines, but how these cell
populations are coordinated under conditions of pathogen threat are not fully understood. Interleukin-22 (IL-22)
is a cytokine of the IL-10 family produced by type 3 immune cells, such as group 3 innate lymphoid cells (ILC3s)
and cells of the Th17 pathway that acts on epithelial cells of barrier tissues to prevent invasion of extracellular
pathogens. How IL-22 acts to coordinate intestinal barrier function remains undefined. Like many immune
cytokines that participate in host defense, IL-22 is upregulated in chronic immune-mediated diseases, and it
appears to play a protective role in inflammatory bowel disease (IBD), presumably by restraining epithelial
damage caused by dysregulated T cell responses to constituents of the intestinal microbiome. However, pro-
proliferative actions of IL-22 have also been implicated in malignant transformation of colonic epithelial cells that
leads to colorectal cancer (CRC). We and others have shown that during infectious colitis modeled by the
enteropathogen, C. rodentium, there are two phases of IL-22 production that can be distinguished: an early
phase dominated by IL-22+ innate immune cells, which is followed by a late phase dominated by IL-22+ T cells.
While both innate and adaptive immune cells produce IL-22 during infection, the respective contributions to
barrier protection are unknown, as are details of the mechanisms by which IL-22 acts. In preliminary studies that
have employed novel IL-22 reporter/conditional knockout (cKO) mice with which to track and/or delete specific
subsets of IL-22-producing immune cells, we have found that the locations and functions of IL-22–producing
cells are distinct during C. rodentium infection. Innate immune cells, dominated by ILC3s, are primarily located
in and restricted to isolated lymphoid follicles, and their release of IL-22 activated by IL-23 acts long-range to
activate surface colonic epithelial cells at initial sites of bacterial colonization. Remarkably, however, ILC3s fail
to protect the intestinal crypts, which are invaded by bacteria in mice with IL-22 deficiency targeted to T cells.
Thus, IL-22–producing T cells are indispensable for protection of the intestinal crypts via their activation of crypt-
lining epithelium. Moreover, we have discovered new heterogeneity within colonic absorptive enterocytes and
find that IL-22-producing T cells differentially activate these populations for increased shedding and production
of neutrophil-recruiting chemokines. In this proposal we will define mechanisms by which innate and adaptive
immune cells are specialized for distinct IL-22–dependent actions on different subsets of colonic epithelial cells,
focusing on novel functions of IL-22+ T cells to protect colonic crypts from bacterial invasion. These studies hold
promise to reveal new insights into specialization of immune cell subsets in intestinal host defense and
mechanisms that control intestinal inflammation in IBD and CRC.

Public health relevance
Coordination of Innate and Adaptive Immunity in Intestinal Barrier Defense. This proposal will generate new insights into mechanisms by which IL-22-producing innate and adaptive immune cells are coordinated to act on newly defined subsets of intestinal epithelial cells to protect the intestinal barrier under threat by enteropathogenic bacteria. These studies hold promise to reveal new insights into specialization of immune cell subsets in intestinal host defense and mechanisms that control intestinal inflammation in inflammatory bowel disease and colorectal cancer.